Laser particles for multi-dimensional single-cell analysis

Project Summary
The broad objective of this proposed work is to advance single-cell analysis by introducing novel cell-barcoding
technologies. Understanding cells is a cornerstone of life sciences. Single-cell sequencing led to a paradigm
shift in our approach to analyze cells from ensembles to individual cells. Unfortunately, the current single-cell
analysis techniques are almost exclusively static, performed ex vivo, and thus cannot easily probe the dynamic
cellular processes. Beyond static analysis, the next important step is to add more dimensions: everything that
makes a cell a living entity, including temporal changes, spatial movement, interactions with other cells in vivo.
This project will develop laser particles (LPs), which can be read optically in real time and repeatedly as
needed, for multi-dimensional single-cell analysis. With the optical barcode, it is possible to acquire data from a
cell at different times, locations and apparatuses, and compile the data to produce a full account of the cell. A
combination of LPs with oligonucleotide barcodes enables a breakthrough approach acquiring large-scale data
from in vivo physiology to molecular omics using multiple instruments in series. This project is organized in
three specific aims. Aim 1 develops large-scale LP barcodes combined with oligo barcodes. Aim 2 constructs
several instruments integrating LP barcode readers into commercial platforms. Aim 3 involves validation
studies to demonstrate the immediate utilities of the new technologies. The optical barcoding is expected to
make a paradigm change in single-cell analysis. This will transform the way multi-dimensional single-cell
analysis is used for scientific discovery and diagnostic and therapeutic applications in healthcare.

Public health relevance
Project Narrative Learning about how cells work and what happens when they don’t work properly teaches us how to keep us healthy and fight diseases. This project will develop new technologies to enhance our ability to study individual cells and their collective working. Therefore, this contributes to fundamental understanding and their applications to improved diagnosis and treatment.